Immune regulation of arenavirus infections in the placenta

Project Summary.
The rodent-borne arenaviruses can cause severe hemorrhagic fevers; several of these potential pandemic
pathogens have been noted to cause high rates of maternal mortality, congenital infection, and/or fetal demise
when pregnant people are infected. The objective of this project is to determine how arenavirus infection
causes adverse pregnancy outcomes. Clinical observations that Lassa virus (LASV) replicates to high titer in
the placenta prompted us to conduct a preliminary study using in vitro models of the human placenta and
experimental guinea pig infections with an arenavirus that is not pathogenic in humans, Pichinde virus (PICV),
to ascertain the role of infection at the maternal fetal interface in severe disease. We found that PICV
replicates to high titers in undifferentiated and differentiated first trimester human trophoblasts and explants
derived from term placenta. Furthermore, infection during pregnancy led to fetal demise, high viral loads in the
placenta and decidua, and low rates of congenital infection in guinea pigs. We hypothesize that the placenta
and decidua serve as a reservoir for arenavirus replication and that the antiviral immune response to infection
at the maternal-fetal interface leads to placental dysfunction. This project will use a combination of methods
and models that include diverse New World (PICV and Junin virus [JUNV]) and Old World (LASV and
lymphocytic choriomeningitis virus [LCMV]) viruses to reveal how arenaviruses circumvent host defense to
infect the placenta and cause severe disease. The placenta is generally an effective barrier against the
bloodborne transmission of pathogens and primary trophoblasts are broadly restrictive to viral infection. Using
a genetically tractable model of the first trimester placenta, human trophoblast stem cells, and term placental
explants, we will investigate the viral factors that allow arenaviruses to circumvent innate and intrinsic immunity
and establish productive infections in trophoblasts (Aim 1). We will next use guinea pigs to assess how the
immune response to arenavirus infection during pregnancy either causes placental dysfunction or may be
harnessed to protect the mother and fetus (Aim 2). A detailed study of PICV pathogenesis at the maternal-fetal
interface will be complemented with experiments using JUNV and LASV to determine whether these highly
pathogenic viruses have a similar tropism for and effects on the placenta and decidua. The completion of this
project will address a critical knowledge gap by revealing the mechanisms by which arenaviruses damage the
placenta and cause pregnancy complications, informing the future development of much-needed therapies to
minimize harm to pregnant people and their offspring.

Public health relevance
Project Narrative. Arenavirus infection during pregnancy can cause debilitating congenital infections and high rates of maternal and fetal mortality. This project will use a combination of in vitro models of the human placenta and experimental infections in guinea pigs to illuminate how these emerging viruses establish productive infections in the placenta and the role of viral replication at the maternal-fetal interface in severe disease.